Epithelial sodium channels in endothelial cells and arterial stiffening

Project Summary/Abstract
Epidemiological data have established an increased incidence of cardiovascular disease events in
obese individuals, with these events being strongly associated with excessive arterial stiffness. Elevated
aldosterone levels and activation of vascular mineralocorticoid receptors (MRs) contribute to obesity related
arterial stiffening. Studies by our group and others have further shown that enhanced endothelial cell (EC)
mineralocorticoid receptor (ECMR) and its downstream epithelial sodium channel (EnNaC) signaling, induce
arterial and EC stiffening together with oxidative stress and inflammation. Conversely, ECMR/EnNaC deletion
prevents diet or aldosterone induced excessive endothelial and arterial stiffness. Our recent data further
indicate that activation of the ECMR increases expression of EC deubiquitinating enzymes and that endothelial
ubiquitin-specific protease 8 (ECUSP8) plays a dominant role in preventing EnNaC ubiquitination and
degradation, leading to increases in EC endosomal EnNaC. Moreover, enhanced ECMR/ECUSP8 signaling
also promotes endosomal EnNaC trafficking and release of exosomal EnNaC. Importantly, exosomal EnNaC,
released from endosomes, is re-uptaken and in turn impacts on EC/vascular smooth muscle cell (VSMC) and
arterial stiffening. Our research hypothesis is that ECMR activation enhances ECUSP8 signaling that increases
endosomal EnNaC, endosome trafficking, plasma membrane EnNaC, and release of exosomal EnNaC,
resulting in EC/VSMC and arterial stiffening. This notion is supported by the fact that obesity is a major public
health issue in the United States, and it is associated with cardiovascular MR activation and vascular disease.
To address this hypothesis in vivo and in vitro, models of ECMR/ECUSP8/EnNaC activation will include a high
fat, high sucrose diet (diet induced obesity) and aldosterone administration, respectively. A cross-sectional
human study will be included to investigate the correlation between plasma exosomal EnNaC and arterial
stiffening in clinically obese and hypertensive patients. Aim 1 of this application proposes to determine whether
ECMR activation enhances ECUSP8 signaling that increases endosomal EnNaC, endosome trafficking,
plasma membrane EnNaC content, and EC and arterial stiffening. Aim 2 will determine determine whether
ECUSP8 signaling increases release of EC derived exosomal EnNaC that is uptaken by ECs/VSMCs and in
turn impacts on arterial stiffening. The proposed innovative research program will provide enhanced
understanding of the interactions between ECMR/ECUSP8/EnNaC activation, endosome trafficking, release of
exosmes, and identify novel therapeutic targets and strategies for the early diagnosis and prevention of obesity
induced vascular stiffening and related cardiovascular complications.

Public health relevance
Project Narrative One early marker for cardiovascular disease is the process called “arterial stiffness”. However, the mechanisms of Western diet (high in fat and refined carbohydrates) and activation of the renin angiotensin– aldosterone system on arterial stiffness are poorly understood. Understanding the biochemical pathways leading to arterial stiffness should lead to specific interventional strategies, including new drugs and dietary interventions to prevent cardiovascular events in obese individuals.